Community Engagement Core

PROJECT ABSTRACT – Component: Community Engagement Core (CEC)
The Community Engagement Core (CEC) in the Southwest Center for Outreach and Resilience in Climate and
Health (SCORCH) will play an integral part in developing and maintaining trusted relationships with
communities and decision-makers to meet the Center’s mission to improve health equity across the lifespan.
The CEC will oversee the Research-Solution-Action pipeline integral to SCORCH’s mission. The core will
contain a Community Advisory Board (CAB) to engage non-academic, community, and practice partners
external to the University of Arizona (UArizona). The CAB will ensure research and capacity-building activities
are community-driven and designed to address community needs. The vision of the CEC is to emphasize an
equitable process of community engagement to inform pilot projects, and translation of information to better
understand the landscape of community needs and actions through their own words. The CEC will apply this
vision through the following three Aims: 1) utilize equitable engagement strategies including a CAB to ensure
SCORCH activities align with community concerns and inform translation and dissemination of findings; 2)
conduct a needs assessment to identify climate and health concerns, gaps, and opportunities; and 3) evaluate
the effectiveness of CEC key activities using the NIEHS’ Partnerships for Environmental Public Health
Evaluation Metrics.